Administrative Supplement for Childcare Costs

Project Summary
Parent Award 1F32GM139371-01A1
Biomolecules are emerging as an important class of therapeutics. Biomolecules enable exciting new therapies
including targeting protein-protein interactions with peptides and mini-proteins, gene editing methods with Cas9
complexes, and mRNA knockdown using chemically modified RNA. Delivery of these macromolecules to the
cytosol is critical. However, quantitative assessment of cell-penetration remains challenging. Recently, the
Kritzer lab reported CAPA, the Chloroalkane Penetration Assay, to address this challenge. In this assay, a
chloroalkane linker is attached to a biomolecule of interest and incubated with a stable HaloTag-expressing
HeLa cell line. As the biomolecule reaches the cytosol, the chloroalkane linker covalently binds to HaloTag.
The cells are then incubated with a chloroalkane-dye that reacts with any remaining HaloTag. After washing
away unreacted dye, cells are then analyzed using flow cytometry. Using this method, fluorescence intensity is
inversely proportional to the amount of cellular penetration of the biomolecule.
Despite the success of CAPA, the assay is ultimately limited in scope. The inverse relationship between
cytosolic localization and fluorescence intensity limits assay sensitivity and the necessary wash steps prevent
in vivo applications. To circumvent these shortcomings, we propose developing a fluorogenic CAPA system. In
this assay a fluorogenic dye will be conjugated to a biomolecule of interest and fluorescence will turn-on upon
covalent reaction with HaloTag in the cytosol. Few fluorogenic dyes have been previously reported for HaloTag
or similar systems, and these dyes display low fluorescence turn-on and/or slow conjugation kinetics –
parameters that make them poorly suited for cell-based assays. For the first time, we will apply molecular
evolution to optimize HaloTag-dye pairs, with the goal of producing a system with 1000-fold increase in
fluorescence upon HaloTag-dye reaction, and reaction kinetics similar to WT HaloTag. Successful completion
of the proposed project will yield a fluorogenic HaloTag system that will greatly improve the throughput,
sensitivity, and time resolution of the CAPA method. Long-term, a fluorogenic dye-HaloTag pair will enable in
vivo assays such as measuring cytosolic delivery and pharmacokinetics in live animals, as well as a methods
that can measure directly time-resolved cellular penetration. The proposed project will provide new methods to
benefit the drug development pipeline, advancing biomolecules as treatments for human diseases.

Public health relevance
Project Narrative Parent Award 1F32GM139371-01A1 Large biomolecules are exciting new classes of therapeutics, but delivery into the cell remains a central challenge. We describe the development of an engineered protein system that will enable quantitative assessment of cellular penetration of biomolecules. Applying this system within robust cell-penetration assays will enable more rapid development of biological therapeutics.